Simulation to Improve Infection Prevention and Patient Safety: The SIPPS Trial

Standard precautions (SP) are a fundamental set of actions, including hand hygiene and use of
personal protective equipment and sharps safety devices, that every healthcare provider should perform in
every contact with every patient to prevent patient healthcare associated infections (HAIs) and occupational
blood-borne pathogen exposures. Despite well established, longstanding guidelines and usual training, SP are
not reliably practiced, with self-reported adherence among nurses (who have the largest proportion of direct
patient contact in acute care) less than 50%. HAIs are a substantial public health problem affecting
approximately 2 million patients annually, resulting in 99,000 estimated deaths and occupational blood-borne
pathogen exposures to 1 in 25 registered nurses. One promising mechanism that may improve SP adherence
is simulation training, an emerging and effective educational approach to enhance healthcare workers'
performance. This study will test a simulation intervention designed to improve provider performance
of SP and prevent HAIs and occupational blood-borne pathogen exposures.
The aims of this project, “Simulation to Improve Infection Prevention and Patient Safety: The SIPPS
Trial,” are to: 1) determine the effect of simulation training on nurse knowledge, observed SP adherence, and
HAI and nurse blood-borne pathogen exposure rates; 2) determine whether patient safety culture modifies the
effect of training on observed SP adherence and knowledge; and 3) determine maximal duration
(sustainability) of the simulation intervention on clinical performance of SP adherence. Our research objectives,
methodology, specification of measures, and simulation implementation plan are innovatively guided by both a
conceptual framework (Human Factors Framework) and implementation model (Consolidated Framework for
Implementation Research). We will conduct a 5-year group-randomized, group-interventional trial to test a
clinical in-situ (i.e., taking place in a live, operational, clinical setting) simulation training intervention and
include approximately 336 direct care registered nurses from a total of 12 units from two hospitals in two
states. Unique survey, direct observation, focus group, and secondary data will be collected and aggregated to
answer our research questions. This project will be supported by the expertise and resources from world-class
academic and clinical settings committed to advancing patient safety through simulation research. Results will
be disseminated in an in-situ toolkit to include a SP curriculum and video training. Hospitalized patients,
including women and minorities, the elderly, inner city residents, and the chronically ill - AHRQ priority
populations - serve to benefit from improved adherence to standard precautions, and health care workers will
benefit from enhanced “real world” training and support to reduce their exposure to blood-borne pathogens.
Ultimately, knowledge gained from this prioritized research will inform key stakeholders of the vital role that
simulation training performs in patient safety and in advancing national aims for healthcare improvement.

Public health relevance
PROJECT NARRATIVE Nearly one in 25 hospitalized patients has a healthcare associated infection at any given time, and one in 25 nurses suffers a blood-borne exposure every year. Basic procedures termed “standard precautions” may prevent these outcomes, but they are not regularly used by healthcare workers. This study will test a simulation intervention designed to improve adherence to standard precautions and prevent healthcare associated infections and occupational blood-borne pathogen exposures in hospitals.